The University of North Carolina Center for AIDS Research

Project Summary-Administrative Core
Over the past two decades, the UNC CFAR Administrative Core has developed and
maintained synergistic partnerships with faculty and students at local Historically Black College
and Universities (HBCUs) in North Carolina. This engagement is based on two fundamental
beliefs: (1) faculty at HBCUs have unique and important contributions to make in understanding
the HIV epidemic, and (2) providing formative experiences in research for students at HBCUs is
an important contribution to the next generation of investigators. Building upon these principles,
we have collaborated with North Carolina Central University (NCCU) and North Carolina Agricultural
and Technical State University (NC A&T) through internship programs, development awards, and
administrative supplements.
With initial funding (2021-22) from the CFAR Diversity, Equity, and Inclusion Pipeline Initiative
(CDEIPI), coordinated by the DC CFAR we created the North Carolina Pathway for Inclusive
Excellence (NC-PIE) in collaboration with NCCU and NC A&T. NC-PIE is a sustainable, yearlong
graduate and undergraduate student pathway program designed to enhance inclusion in the
biomedical sciences. This funding was successfully renewed through CFAR Administrative
supplements for 2022-23 and 2023-24.
In this application we build on lessons learned to further optimize the NC-PIE student experience
and provide additional opportunities for exposure. In addition, we have created two new
opportunities: 1) we will partner with UNC Dept. of Microbiology and Immunology to enhance an
immersive summer research experience the HBCU Bridge Summer Research Opportunity
Program (HBCU-Bridge-SROP) and 2) we will develop a new undergraduate lecture series
“Principles of HIV” that will be offered as part of the Public Health education curriculum at
NCCU.
This revision application housed within the Administrative core, will afford novel professional
learning experiences, catalyze partnerships to create new research, training and mentoring
opportunities and advance knowledge of infectious diseases especially HIV and allied health
careers. CFAR Administrative infrastructure is in place to support the aims of this revision
application.